National Xenopus Resource Center

Project Summary This grant supports a project to expand the National Xenopus Resource (NXR) to allow it to sell more wild type Xenopus laevis frogs. The need for this expansion is the recent closure of Nasco, one of the main commercial suppliers of Xenopus laevis. The current expansion would entail purchase of new recirculating aquatic systems and renovation of the room where the equipment will be located. The equipment is being purchased from Iwaki Aquatic as this is the same systems already in use in the NXR. Alterations and renovations of the room will be performed by staff at the Marine Biological Laboratory (MBL) as well as outside contractors. This expansion will allow the NXR to grow up to 1,000 additional wild type X. laevis for the research community. This should help alleviate the loss of frogs from the closure of Nasco.

Public health relevance
Project Narrative Research using the amphibian Xenopus, because of unique advantages as an experimental system, has revealed key insights in many domains of biomedical research, including cell biology, development, neurobiology, physiology and signal transduction, achievements that are supported by having a centralized National Xenopus Resource for raising and distributing animals and disseminating the most current technology to the research community. In each of these areas research has led to significant insights about the causes of human diseases, including cancer, birth defects, diabetes and neurological disease, and provided key underpinnings for the field of regenerative medicine.